Identifying and testing a tailored strategy to achieve equity in blood pressure control in PACT

Background: Hypertension and blood pressure (BP) control inequities are a leading modifiable risk factor for
the higher cardiovascular disease (CVD) morbidity and mortality experienced by racial/ethnic minority
Americans. Team based care, an evidence-based practice, may be effective in reducing BP control disparities.
However, despite VA Primary Aligned Care Team (PACT) implementation, BP control race/ethnic inequities
persist. This highlights a need tailored bundle of implementation strategies (i.e., playbook) to address the
unique needs of minority Veterans. The 2020 VA/DoD Hypertension Clinical Practice Guideline recommends a
threshold for medication initiation in high CVD-risk patients and for medication intensification in all hypertensive
patients be lowered by 10 mm Hg (vs older guidelines) to systolic BP 130 mm Hg (intensive BP control), if
aligned with clinical judgement and patient preference. Achieving and maintaining intensive BP control could
avert half a million CVD events in the US overall over 10 years, however there is a need for implementation
playbooks that ensure the known benefits of intensive BP control are experienced equally.
Significance: Our goal is to reduce hypertension-related morbidity and mortality disparities in VHA by
optimizing antihypertensive medication management in PACT. Achieving and maintaining intensive BP control
may avert half a million CVD events over 10 years in the US.
Innovation and Impact: Our study will leverage the VHA Office of Health Equity Primary Care Equity
Dashboard (PCED) launched in 2021, an audit feedback tool, may be an important strategy to a population
health management approach, to support team-based playbooks designed to mitigate hypertension disparities
and support evidence based practice update among race/ethnic minority Veterans.
Specific Aims: Aim 1) Contrast patient-, provider-, and facility-level factors associated with intensive
antihypertensive management (initiation, adherence, and intensification) and BP control by race/ethnicity; Aim
2) Using qualitative data, identify patient, provider- and facility-barriers and facilitators relevant to intensive
antihypertensive management (initiation, adherence, and intensification) and BP control by race/ethnicity; and
Aim 3) Codesign two intensive BP control population health management implementation playbooks tailored to
reduce BP inequities and prototype and pilot test the playbooks in PACT.
Methodology: In Aim 1, we will complete a hierarchical analysis of patient (e.g. sex, age, socio-demographics,
comorbidities, non-VA community and virtual healthcare use), provider (e.g. specialty, patient-provider visit
frequency), and facility (e.g. urban/rural status, geographic location, % racial minorities served, academic
affiliation, PACT implementation) factors associated with intensive BP management. In Aim 2, applying the
Theoretical Domains Framework in conjunction with the Chronic Care Model, we will collect and analyze semi-
structured interview data from 120 Veterans and 60 PACT staff and providers from the Salt Lake City and DC
VAMCs. In Aim 3, with our stakeholders we will identify and prioritize multilevel barriers improve equitable BP
control. Next, we will link the barriers to evidence-based behavior change techniques and tools, such as
leveraging the PCED. We will iteratively tailor and prototype two multilevel playbooks, one will focus on the
facility/team level and the other on the provider/patient level. We will pilot both playbooks at the Salt Lake City
and DC VAMCs to collect usability, feasibility, and acceptance data.
Next Steps/Implementation: By completing these aims, we will provide an actionable, evidence-based, and
comprehensive understanding of the gaps and barriers related to intensive BP control in the VHA. This
knowledge will lead to an evaluation study of the tailored intensive BP management implementation playbooks.

Public health relevance
Over 1 million Black and 0.5 million Hispanic Veterans are enrolled in the Veterans Health Administration (VHA) and the percentage of race and ethnic minorities served by the VHA is expected to continue to increase over the next several decades. Hypertension is the most common chronic condition in Black and Hispanic adults and is a top risk factor for cardiovascular disease morbidity and mortality. Also, Black Veterans are more likely to die due to stroke compared to White Veterans in the VHA and controlling blood pressure is recognized a one of the most important ways to prevent stroke. Understanding the reasons for racial and ethnic differences in blood pressure treatment in Veterans is important for developing implementation plans that support high quality equitable care for all Veterans. This research is consistent with the VA Blueprint for Excellence Transformational Actions: “to understand and eliminate health inequalities.”